Evaluation of extracellular matrix gel for adhesion prevention and tissue healing intendon surgery

Project Summary
Approximately 32M musculoskeletal injuries in the US cost nearly $322B annually (1). The high economic
burden is due in part to post-operative scar formation (i.e., adhesions), which is the leading cause of disability
following tendon surgery (4, 5). We are developing a sprayable adhesion barrier derived from extracellular matrix
(ECM Spray), which serves as a mechanical barrier and elicits a healing response from the patient’s own body
to prevent adhesions from forming. Around 1.5M patients suffer flexor tendon injuries each year and as many as
30-40% of these individuals will subsequently have limited range of motion due to adhesions (6). Current options
to mitigate adhesions are limited and flawed, and there is an unmet need for a technology which can safely and
effectively prevent adhesion formation to maintain normal joint function after tendon injury. ECM Spray is
thermally responsive, forming a thin film hydrogel over the tissue where applied and prevents adhesions by
acting as a mechanical barrier between adjacent tissues. Application of ECM Spray as the last step of a surgical
procedure resulted in >70% reduction on post-operative adhesions in abdominal and pelvic animal models of
adhesion formation. A major limitation of currently available orthopedic tendon protectors / adhesion barriers is
that they are bulky sheets unable to conform to the region of the repaired flexor tendon and therefore impair
tendon movement / gliding. Newer thin sheet products are available, but surgeons describe them as performing
like “wet toilet paper” because they disintegrate upon hydration. ECM Spray is applied as a liquid, rather than a
sheet, to conform to the repaired flexor tendon and surrounding flexor tendon sheath. Past attempts at
developing sprayable adhesion barriers have been unsuccessful, in part because of impaired tissue healing after
application. While it remains unknown what impact ECM Spray will have upon tendon healing, we have shown
that ECM Spray acts as an inductive scaffold to support constitutive repair of the peritoneum. Based upon these
data, the objective of the present study is to determine ECM Spray’s safety, efficacy, and usability in orthopedic
surgery following flexor tendon injury. In Aim 1, we will characterize tenocyte cellular response to ECM Spray,
which will determine if ECM is biocompatible and supportive of tenocyte and synoviocyte growth. In Aim 2, we
will determine if ECM Spray effective for reducing tendon adhesion formation without compromising the
biomechanics of healing tendons. In Aim 3, we will demonstrate usability in human anatomy, which is critical to
surgeon adoption and commercialization. Results from this safe-by-design approach will lead to key research
and development milestones necessary for use of ECM Spray in orthopedic surgery and could ultimately improve
the lives of the millions affected each year by adhesion-related morbidity.

Public health relevance
Project Narrative Despite improvements in surgical and rehabilitative techniques, there are still no good options for preventing flexor tendon adhesions (i.e., scar tissue bands that form when tissues heal without intervention). The patient and economic impact of adhesions following flexor tendon surgery is unacceptable, with 30-40% adhesion related complications in 1.5M+ patients annually in the US with lacerating hand injuries and tendon repair surgeries. Based upon previous data that demonstrated our newly developed extracellular matrix spray (ECM Spray) material blocks adhesion formation in abdominopelvic models, the objective of the present study is to determine if ECM Spray can mitigate the formation of post-operative tendon adhesions—without compromising tendon healing / biomechanics—by examining cellular response in vitro, measuring tendon adhesion rate and integrity of healing / restoration of function in vivo, and evaluating usability in human anatomy in a cadaver model. This proposal addresses an unmet clinical need and the potential—to reduce morbidity and improve the quality of life for millions of patients by accelerating recovery and restoration of tendon and joint mobility—is highly relevant and worthy of investigation.